Bloomington Drosophila Stock Center at Indiana University

Project Summary
The Bloomington Drosophila Stock Center (BDSC) collects, curates, maintains and distributes genetically
defined strains of the fly Drosophila melanogaster to support the biomedical research community. It is the
largest and most comprehensive Drosophila stock collection in the world, and it is central to the success of
many research projects—including over 830 active NIH grants. Effective use of BDSC stock resources requires
that scientists have extensive information about the defined genetic components in stocks (e.g. mutations and
chromosomal aberrations) and about the stocks themselves (e.g. provenance, experimental uses and care
instructions). For decades, the BDSC has shared the task of providing stock information to scientists: FlyBase,
the online knowledgebase, has archived and presented information about stock components in the context of
the scientific literature while the BDSC has provided information about the stocks as objects. This arrangement
has been efficient and effective, and most model organism stock centers have similar arrangements with their
respective knowledgebases, but the recent, abrupt suspension of FlyBase funding is ending the longstanding,
synergistic relationship between FlyBase and the BDSC.
In recent years, NHGRI has undertaken an effort to consolidate seven model organism knowledgebases,
including FlyBase, under a single umbrella organization, the Alliance of Genome Resources. Incorporation of
these knowledgebases into a single database with a single website was to be completed by 2029. Abrupt
termination of the FlyBase project early in this transition jeopardizes these consolidation efforts and will have
devastating consequences for the BDSC and for biomedical researchers in general. In this proposal, the BDSC
presents a collaborative plan to accelerate the transition of stock-associated FlyBase data to the Alliance and
to reestablish functionalities that support stock distribution by the BDSC on the Alliance website. With these
plans, the BDSC hopes to avoid the destabilizing effects of losing informational services integral to its
operations.

Public health relevance
Project narrative The Bloomington Drosophila Stock Center has relied on FlyBase, a knowledgebase dedicated to archiving data about Drosophila genomics and genetics, to distribute information regarding the genetic components of Drosophila stocks and to help guide scientists towards appropriate stocks for experimentation. The loss of FlyBase services supporting stock distribution activities will destabilize the Bloomington Drosophila Stock Center because it depends on program income from stock distribution to fund its operations. To compensate for the unexpected discontinuation of the FlyBase project, the Bloomington Drosophila Stock Center will partner with the Alliance of Genome Resources to accelerate the assimilation of the FlyBase database and the presentation of information relevant to the experimental use of Drosophila stocks.